Alzheimer's Disease Viewed as a Neurovascular Inflammatory Disorder

Alzheimer’s Disease Viewed as a Neurovascular Inflammatory Disorder PROJECT SUMMARY / ABSTRACT Alzheimer’s disease (AD) is a devastating neurodegenerative disorder lacking effective treatments. Most clinical trials testing the long-standing amyloid hypothesis of AD have shown little promise. The future of novel treatments targeting other pathophysiological processes in the disease is uncertain. Growing evidence supports a role for neurovascular inflammation as a major causative or exacerbating factor in AD onset and progression. However, the scientific community has yet to label AD a vascular disease and questions remain about the viability of neurovascular inflammation as a potential therapeutic target. To address this controversy head-on, the New York Academy of Sciences will present a 1-day symposium and simulcast Webinar, “Alzheimer’s Disease Viewed as a Neurovascular Inflammatory Disorder” on 12/6/2016. The goal of this symposium is to evaluate clinical and preclinical data investigating the role of neurovascular pathology in the development of AD. Critical barriers to understanding how to clinically test vascular-based hypotheses for the treatment of AD will be discussed, including recent imaging advances for monitoring disease progression. Moreover, emerging science on molecular and physiological processes that can be leveraged as targets for novel therapeutics will be presented. This symposium will fill an important gap in the conference landscape, presenting a focused, in-depth discussion on the synergies between AD and vascular disease research, building upon the recently defined need to better understand neurovascular dysregulation in AD and vascular dementia (36). This landmark event will unite 200 in-person basic, translational, and clinical researchers — along with a global audience of Webinar participants — from academia, industry, government, and non-profit organizations, working on neurodegenerative disorders and vascular disease in an effort to understand, prevent, and treat AD and vascular dementias such as small vessel disease (SVD). Sessions will address 5 central aims: (i) Elucidate the relationship between genetic information and neurovascular pathology in AD and SVD; (ii) Explore novel molecular targets and physiological processes critical to vascular function and CNS health, using human studies and animal models; (iii) Describe clinical aspects of neurovascular dysregulation and inflammation in AD and SVD and identify biomarkers for vascular-based mechanisms; (iv) Identify knowledge gaps and future research required for breakthroughs in prevention and treatment of AD; and (v) Showcase and encourage the participation of Early-Career, female, and Underrepresented Minority investigators via short talks, poster presentations and prizes, travel fellowships, and discounted registration. In addition, the NINDS’ specific goal of disseminating information will be met through a simulcast Webinar and publication of an enduring open-access Academy eBriefing. A collaborative, multidisciplinary approach will be critical to meeting the urgent unmet need for AD patients. To that end, this event will consider new disease mechanisms and therapeutic targets for AD, from a broad range of perspectives.

Public health relevance
Alzheimer's Disease Viewed as a Neurovascular Inflammatory Disorder PROJECT NARRATIVE Alzheimer's disease (AD) constitutes a significant socioeconomic burden, which will only continue to increase as the global population ages. Significant headway into elucidating disease mechansims has been made, however this progress has not translated into effective strategies for preventing, treating, or curing this crippling disorder. Emerging research suggests a strong link between brain vascular dysfunction and AD. However, despite mounting evidence for vascular pathology in AD, its role in aetiology is hotly debated. As a result, there is a clear need to map the molecular and cellular mechanisms that link vascular disease and AD. A clear mapping will better define the path towards biomarker identification, and identify strategies for developing and testing therapies aimed at improving neurovascular function in AD. In order to achieve this important goal, the New York Academy of Sciences will confront this controversy head-on by convening “Alzheimer's Disease Viewed as a Neurovascular Inflammatory Disorder”. The symposium, also simulcast via Webinar, will gather experts in the field along with young investigators, providing a neutral forum for approximately 200 in-person attendees plus remote participants to discuss the current state of knowledge and identify important unknowns, tailoring the direction of future research. Discussion will highlight basic research and clinical science elucidating the mechanisms underlying vascular contributions to cognitive impairment and dementia (VCID). The symposium will provide a fertile environment for developing the foundations of future collaboration, helping to identify synergies and complementarities between lines of research. In turn, this will allow for the development of a repository of cutting-edge science that will be captured in open-access online formats, to ensure that the scientific information exchanged at the meeting is disseminated to the global research and medical communities.